Workshop on the Pathology of Mouse Models for Human Disease

This proposal is a request for a 4-year continuation of NIH Support for a “Workshop on the Pathology of Mouse Models
for Human Disease”. For 20 years, this workshop was sponsored by The Jackson Laboratory in Bar Harbor, Maine. We
now plan to hold this workshop at St. Jude Children’s Research Hospital in Memphis, Tennessee. The previous PI, Dr.
John Sundberg, is a key person on this grant and will remain on the organizing committee until the course has
successfully transitioned to St. Jude. The focus of the workshop will continue to be the mouse as a biomedical research
model. The mouse is heavily utilized as a model of human diseases, and there are increasing demands on pathologists to
provide clinically relevant, quantitative morphological and molecular data on mouse models. The primary goal of this
workshop is to train the next generation of pathologists (veterinary and medical) and biomedical researchers on what
pathologists can contribute to the design and evaluation of experiments that use mice to model human diseases. Access
to well-trained pathologists with specialization in the mouse as a research model is essential given the accelerated
production of novel mutant mouse models, as well as for preclinical safety and efficacy studies. Existing pathology
residency programs at Veterinary and Medical schools provide little to no training on the mouse since their focus is on
companion/farm animals and humans, respectively. Mouse-specific pathology training is essential because
misinterpretation of species-specific anatomical features and background lesions is unfortunately far too common in the
scientific literature, and this erroneous data negatively impacts subsequent biomedical research. The long-term
objectives are two-fold: 1) to enhance the ability of participants to correctly interpret spontaneous and experimentally
induced lesions in mice and 2) to demonstrate how pathologists can effectively apply new technologies to enhance the
value of research studies. The relatively small size of the workshop is intended to facilitate faculty-attendee interactions
and foster the development of professional relationships and networks. The workshop program will continue to be built
around a core group of experienced comparative pathologists who specialize in mouse model development at several
research institutions across the United States. Additional training will be provided by invited experts, as well as onsite St.
Jude researchers (PhD and MD). Specific fields of study to be covered include cancer biology, cellular and gene
therapies, infectious disease pathogenesis and treatment, immunology, neurodegenerative diseases, and other organ
specific abnormalities. The workshop will also include training in and hands-on exposure to the application of
technologies that comparative pathologists use to investigate disease pathogenesis in tissues (e.g., multiplex labeling
and image acquisition, AI-assisted image analysis, and tissue-based spatial biology applications). Given the increasing
need for quantitative analysis of lesions in whole slide images, we are including 8 hours of hands-on bioimage analysis
training targeted at scientists in basic research who want to analyze microscopy data, but do not have a background in
programming or image analysis. This training will be delivered in person. The program will include time for 9
participants to present their own research in platform presentations selected from submitted abstracts.

Public health relevance
NARRATIVE This five-day long “Workshop on the Pathology of Mouse Models for Human Disease” will focus on the development, pathologic characterization, and application of mouse models for the study of human diseases. The program includes didactic lectures and hands-on labs led by experienced comparative pathologists from across the United States in collaboration with basic and clinical research scientists who utilize mouse models. The workshop is organized to facilitate an environment where young investigators, pathologists, and scientists, especially those from under-represented groups, can develop professional networks with others in the field.